Iron independent role for yersiniabactin in Yersinia pestis

SUMMARY
Transitional metals (e.g., Fe, Zn, Mn) are required by bacteria in order to grow. As such, mammals have a
variety of mechanisms to sequester these metals during infection, effectively limiting their availability for use by
bacteria (referred to as nutritional immunity). Yersinia pestis, which causes the human disease plague, needed
to evolve high-affinity metal acquisition mechanisms to overcome nutritional immunity and colonize its hosts.
Because these mechanisms are key to Y. pestis virulence, they represent potential therapeutic targets for the
treatment or prevention of plague. Therefore, our long term goals are to identify the mechanisms used by Y.
pestis to evade host nutritional immunity and define their roles in virulence. Recently, we have made the exciting
discovery that yersiniabactin (Ybt), a siderophore essential for Y. pestis iron (Fe) acquisition, is also able to bind
to zinc (Zn), and contributes to Zn acquisition in vitro. Furthermore, using a hemochromatosis mouse model that
is defective in Fe-mediated nutritional immunity, we demonstrated for the first time that Ybt contributes to
virulence in an Fe-independent manner. Using a Y. pestis mutant defective in Zn acquisition, was also showed
that the host protein calprotectin, which is a key component to Zn-mediated nutritional immunity, is a barrier to
Y. pestis infection, and Ybt contributes to overcoming this barrier in both pneumonic and bubonic plague.
Together, these data are our premise for the conceptually innovative hypothesis that Ybt not only contributes to
virulence through Fe acquisition, but also contributes to Zn acquisition, which aids in overcoming calprotectin
mediated nutritional immunity. In this proposal, we will build on these exciting discoveries. In Aim 1, we will define
the mechanisms that govern metal selectivity of Ybt and the re-acquisition of Ybt-Zn by the bacterium. In Aim 2,
we will define the Ybt secretion mechanisms used by Y. pestis and determine the therapeutic potential of
inhibiting these secretion systems during plague. Finally, in Aim 3, we will define the role of host calprotectin
during plague and the contribution of Ybt to the ability of Y. pestis in overcoming calprotectin mediated Zn
sequestration. Importantly, Ybt is a conserved virulence factor in many Gram-negative bacteria. Therefore, the
data generated from these studies has the potential to provide us with a broader understanding of the role of Ybt
in the virulence of multiple pathogens. Ultimately, these data will provide a foundation for the rational design of
new therapeutic approaches targeting these mechanisms to combat Y. pestis infection.

Public health relevance
PROJECT NARRATIVE Humans have developed mechanisms to restrict bacterial access to metals during infection, and thus, pathogens in turn have evolved high-affinity metal acquisition systems to overcome this restriction. This project will identify the mechanisms used by Yersinia pestis to acquire zinc in order to cause the human disease plague. As metal acquisition is essential for virulence, defining these mechanisms will reveal novel targets for the development of new anti-plague therapeutics.